PORTAL BLOOD FLOW AS MEASURED BY DOPPLER ULTRASOUND IN CIRRHOTIC PATIENTS

To Determine the effect of oral glucose ingestion on portal blood flow as measured by duplex ultrasound in cirrhotic patients.